NORMAL DIFFERENTIATION AND CARCINOGENESIS

Whether normal somatic cell differentiation generally involves irreversible genetic changes is not known. In vertebrates the only known case of directed DNA rearrangements and nucleotide losses concomitant with cell differentiation occurs in some of the lymphocyte genes. However, this laboratory has shown that nuclei of terminally differentiated frog erythrocytes transplanted into first meiotic oocytes can direct the development of feeding tadpoles, the most extensive development obtained from differentiated nuclei. These results demonstrate genetic multipotentiality and widespread activation of the erythrocyte genome. ln this application we propose to transplant erythrocyte nuclei into diplotene oocytes. It is hypothesized that exposure of the nuclei to the molecular components of this earlier stage will result in chromatin remodeled so as to permit more extensive genomic activation and more advanced development, possibly even fertile frogs. In the same system the developmental potential of the totipotent spermatogonial nucleus will be compared to that of the somatic nucleus. Also, some parameters of the molecular basis of genomic activation in nuclear transplants will be examined by studying hemoglobin types and the effect of reduced methylation. Finally, the diplotene oocyte should provide a system for the rigorous analysis of the molecular mechanisms involved not only in the activation of specific genes, but also of an entire genome. Such knowledge could be applied ultimately to controlling cellular disorders in cancer and aging and to enhancing the limited regeneration in humans.